Quantitative MR Imaging of Vascular Factors in Parkinsons Disease

Abstract
Vascular health has been shown to be an important factor in the development of
neurodegenerative diseases like Alzheimer’s and Parkinson’s diseases. Hence, the ability to
measure reliably and quantitatively early hemodynamic changes in the aging brain can be
a powerful tool for diagnosing, studying, and developing treatments.
Arterial Spin Labeling (ASL) magnetic resonance imaging can yield quantitative perfusion images
without the use of contrast agents. We propose that combining new ASL techniques, such as
Velocity Selective Inversion (VSI) labeling pulses and magnetic resonance fingerprinting
(MRF) with deep learning regression methods will allow quantification of multiple
hemodynamic parameters beyond perfusion, thus providing a much more nuanced picture of
the state of the vasculature. We also expect that the new technique will offer dramatic
improvements in SNR, specificity and sensitivity of ASL, and that the proposed techniques will
have many other applications in research and in the clinic.
We propose to use these techniques to fill the knowledge gap regarding the relationship between
vascular changes and Parkinson’s disease and its symptoms, particularly fatigue, whose
pathogenesis is not well understood. If we are successful in this application, future work will use
the hemodynamic parameters of interest as biomarkers to assess risk of neurodegeneration,
determine therapeutic targets, and guide in the development of new therapies.

Public health relevance
Public Health Statement Vascular health is an important factor in the development of neurodegenerative diseases like Alzheimer’s and Parkinson’s diseases We propose to develop a method that can produce quantifiable images of multiple blood flow related parameters with a single scan and without the use of contrast injections. We will use this method to gain a better understanding of the relationship between Parkinson’s disease and cerebral blood flow, and expect that our method will have multiple applications beside Parkinson’s disease.